Macrophage Inflammarafts and Mitochondrial Dysfunction in Atherosclerosis

Project Summary
The excessive accumulation of cholesterol in vascular macrophages is regarded as a leading factor in the
development of vascular inflammation, plaque instability and clinical manifestations of atherosclerosis. However,
recent advances in single cell analyses and our studies suggest that inflammatory genes are predominantly
expressed in macrophages that accumulate cholesterol in the plasma membrane rather than in lipid droplet-
laden macrophage foam cells. Cholesterol and many receptors governing inflammatory responses colocalize in
the ordered plasma membrane microdomains, often designated as lipid rafts. Upon activation, lipid raft resident
and recruited proteins assemble and initiate signaling cascades leading to inflammation. We introduced the term
inflammarafts, defined as enlarged, clustered lipid rafts harboring activated receptors and adaptor molecules
and serving as a scaffold to organize cellular inflammatory responses. We found inflammarafts to be surprisingly
stable in macrophages isolated from atherosclerotic lesions. We further identified apoA-I binding protein (AIBP)
as a key regulator of cellular cholesterol metabolism, which can selectively target inflammarafts via its binding to
TLR4, without disrupting physiological lipid rafts. In preliminary studies, we found that non-foamy macrophages
but not macrophage foam cells expressed inflammarafts, which correlated with atherosclerosis burden. In
addition, hypercholesterolemic AIBP deficient mice, which we created, developed exacerbated atherosclerosis.
In contrast, the AAV-mediated expression of a secreted form of AIBP in the liver reduced atherosclerosis. In
addition, mitochondria in AIBP-deficient cells were morphologically distorted, with a characteristic hyper-
branched and cupped shape, typically associated with oxidative stress. The goal of this proposal is to delineate
mechanisms governing differential inflammaraft dynamics and related mitochondrial dysfunction in macrophage
foam cells and in non-foamy macrophages in atherosclerosis. Specifically, we will test the hypothesis that
reversal of inflammarafts in non-foamy macrophages reduces vascular inflammation and is atheroprotective.
The hypothesis will be tested using genetic and AAV tools to achieve constitutive, macrophage-specific and/or
inducible loss-of-function or gain-of function of cholesterol transporters ABCA1/G1 and/or AIBP and its variant
that does not bind TLR4. In addition, we will test the hypothesis that AIBP protects macrophages from
mitochondrial dysfunction and oxidative stress in atherosclerosis. We will examine mitochondrial architecture
and function in macrophages with loss- and gain-of-function of different forms of AIBP and/or ABCA1/G1.
Methods will include serial block-face scanning electron microscopy (EM) and multi-tilt EM tomography, along
with measures of bioenergetics by Seahorse. To assess the relevance of our hypotheses and the findings to
human cardiovascular disease, we will characterize macrophage inflammarafts and mitochondrial dysfunction in
coronary arteries from explanted hearts of patients with heart failure due to atherosclerotic coronary artery
disease or due to non-ischemic cardiomyopathy, which undergo heart transplant surgery.

Public health relevance
Project Narrative Chronic inflammation contributing to the development of cardiovascular disease is difficult to treat because innate immune cells become primed to a hyperinflammatory response. This research project will address formation of inflammarafts, reprogrammed plasma membrane microdomains hosting complexes of inflammatory receptors, and mitochondrial dysfunction in atherosclerotic lesion macrophages. Strategies to target inflammarafts and mitochondrial dysfunction will advance the development of novel therapeutics to treat atherosclerosis and cardiovascular disease.